RANDOMIZED, DOUBLE-BLIND TRIAL--EFFECT OF ENALAPRILAT/ENALOPRIL POST INFARCTION

To evaluate the effect of Enalaprilat/Enalapril on reducing the degree of ventricular dilation after anterior wall myocardial infarction.